Deep Learning for Automated Aortic Stenosis and Valvular Heart Disease Detection Using a Digital Stethoscope

Project? ?Summary/Abstract This? ?SBIR? ?Phase? ?I? ?project? ?will? ?develop? ?a? ?deep? ?learning-based? ?clinical? ?decision? ?support? ?algorithm for? ?identifying? ?aortic? ?stenosis? ?from? ?heart? ?sounds? ?recorded? ?using? ?the? ?Eko? ?Core? ?Digital Stethoscope.? ?This? ?screening? ?tool? ?will? ?help? ?to? ?decrease? ?the? ?number? ?of? ?patients? ?with? ?severe asymptomatic? ?aortic? ?stenosis? ?that? ?remain? ?undertreated? ?simply? ?because? ?the? ?condition? ?is? ?not diagnosed.? ?Auscultation? ?is? ?commonly? ?the? ?method? ?by? ?which? ?valvular? ?heart? ?disease? ?is? ?first detected,? ?but? ?cases? ?often? ?fail? ?to? ?be? ?referred? ?to? ?echocardiography? ?for? ?diagnosis? ?because clinicians? ?fail? ?to? ?detect? ?heart? ?murmurs,? ?particularly? ?in? ?noisy? ?or? ?rushed? ?environments.? ?To? ?address this? ?challenge,? ?Eko? ?had? ?developed? ?the? ?Core,? ?a? ?digital? ?stethoscope? ?attachment? ?that? ?can? ?be? ?added in-line? ?to? ?a? ?clinician?s? ?existing? ?stethoscope? ?that? ?amplifies? ?heart? ?sounds? ?and? ?streams? ?digitized phonocardiograms? ?to? ?a? ?smartphone,? ?tablet? ?or? ?personal? ?computer.? ?There,? ?the? ?signal? ?can? ?be analyzed? ?with? ?the? ?decision? ?support? ?algorithm? ?we? ?will? ?develop? ?as? ?part? ?of? ?this? ?project.? ?The? ?specific aims? ?of? ?this? ?study? ?are? ?(1)? ?to? ??collect? ?a? ?database? ?with? ?condition-specific? ?recording? ?labels? ?to enable? ?deep? ?learning? ?for? ?heart? ?sounds? ?though? ?clinical? ?data? ?collection? ?at? ?UCSF? ?and? ?(2)? ?to develop? ?and? ?evaluate? ?a? ?deep? ?convolutional? ?neural? ?network-based? ?algorithm? ?trained? ?on? ?the database.? ?By? ?integrating? ?this? ?deep? ?learning? ?algorithm? ?into? ?Eko?s? ?mobile? ?and? ?cloud? ?software platform,? ?currently? ?used? ?by? ?clinicians? ?at? ?over? ?700? ?institutions? ?worldwide,? ?we? ?anticipate? ?this algorithm? ?will? ?enable? ?more? ?accurate? ?screening? ?for? ?aortic? ?stenosis,? ?leading? ?to? ?earlier? ?diagnosis and? ?better? ?patient? ?outcomes.

Public health relevance
SBIR Project Narrative Valvular heart disease, and aortic stenosis in particular, are becoming increasingly prevalent manifestations of poor cardiovascular health in both the developed and developing world. A highly-accurate clinical decision support algorithm that is able to detect aortic stenosis will impact public health by reducing unnecessary referrals for echocardiography and promoting early and accurate diagnosis in underserved areas with limited access to subspecialty care.